Biostatistics Center for Lebers Hereditary Optic Neuropathy (LHON): Gene Therapy Clinical Trial

The Biostatistics Center (BC) for Leber's Hereditary Optic Neuropathy (LHON): Gene Therapy
Clinical Trial will continue its collaboration with Dr. John Guy, escalating to higher doses of the
AAV-ND4 gene therapy investigational product (IP) in this Phase 1 clinical trial. LHON is a
maternally inherited blinding disease of mitochondrial DNA (G11778A mutation in the ND4
gene). Dr. Guy has developed a method for allotopic expression, which is a procedure to
introduce a “nuclear version” of this mitochondrial gene and to then target the cytoplasmically
synthesized protein to the mitochondria with a mitochondrial targeting sequence. The LHON
Gene Therapy Clinical Trial is a Phase 1 clinical trial to evaluate the safety of an open-label,
unilateral, single-dose of intravitreal injection of adenoassociated viral vector (AAV-ND4) LHON
patients. The BC provides biostatistical and coordinating center support for the study.
The BC investigators are an experienced team, who have been involved with ophthalmological
clinical trials since 1985 and collaborated with Dr. Guy on a prospective funded natural history
study of a cohort of LHON families, which included affected patients and carriers. In the
previous funding cycle of this Phase I dose escalation trial, the BC played a critical role in
initiating the trial and ensuring compliant enrollment and post injection follow up of 19 patients,
18 of which demonstrated safety of the low and medium dose AAV-ND4 IP. It is also
responsible for data quality, management, and entry into the 21 CRF part 11 compliant
database. This effort led to the publication of two reports in the peer-reviewed ophthalmology
literature.
The study team now proposes to employ its procedures, developed, implemented, and proven
for the low and medium doses, to escalation of higher doses

Public health relevance
Mutations in mitochondrial DNA lead to a spectrum of diseases. The most common mitochondrial disorder is the blinding disease LHON for which no effective treatment exists. Having previously demonstrated safety of low and medium dose AAV-ND4 gene therapy investigational product for LHON patients, we propose to continue dose escalation to higher doses. If we can show this therapy is safe, it may provide an effective treatment for LHON as well as other mitochondrial diseases of the eye and other organ systems.